VARIED DOSES OF TRIVALENT INFLUENZA BY JET INJECTOR

Administration of vaccines by jet injector (JI) offers several potential advantages over the traditional needle and syringe (N&S) administration of immunizations. The first is potentially improved immunogenicity, which may allow for lower doses of vaccine to be administered. This may reduce the cost per dose of vaccine or allow for a higher dose yield with current production methods. Second, JI administration may be associated with a more rapid rise in antibody titer, resulting in a more immediate conference of protection following vaccination. The third is a reduction of the risk of transmission of blood borne pathogens resulting from improper sterilization of N&S's and inadequate disposal of sharps in developing countries. Lastly, JI administration may be less painful than N&S administration. In this study, healthy adults will be vaccinated with varyng doses of influenza vaccine, by JI and N&S. If adminstration by JI is associated with advantages in terms of tolerability, immunogenicity, or kinetics of antibody rise, this will support further efforts to develop and test JI devices in both adult and pediatric populations.